Iowa Training Program in Kidney and Hypertension Research

Abstract
This application proposes continued funding for an interdisciplinary Iowa Training Program in Kidney and
Hypertension research. The program provides research training for adult and pediatric nephrology fellows as
well as PhD scientists interested in kidney and hypertension research in the University of Iowa, Carver College
of Medicine. The primary purpose of the program is to provide intensive rigorous training for clinicians and
scientists in broad ranges of areas related to kidney biology and disease and hypertension to transform this
knowledge into improvements in patient care. The training program has been continuously funded for the past
25 years. The applicant pool is robust, and the program has filled consistently. The graduates from the
program have published important contributions to biomedical research, and many have obtained faculty
positions and received external funding for their research. The program faculty comprises 41 physician-
scientists and basic scientists from 11 Departments with expertise in a broad range of scientific disciplines that
are relevant to the kidney and hypertension. The training program research portfolio is organized into five
themes based on and integrated with the existing strengths of research on campus: ion transport physiology
and cell biology, renal genetics, hypertension, diabetes and renal metabolic diseases, and clinical and
translation research in kidney diseases. The training curriculum includes mentored research training, didactic
courses that include optional elective graduate-level courses, grant-writing workshop, and required courses in
ethics and the responsible conduct of research, and attendance to journal clubs, works-in-progress and
research seminar series. Specific training opportunities for patient-oriented research consist of a certification
program in patient-oriented research and a Master or PhD degree in Translational Medicine.

Public health relevance
There remain significant gaps in our understanding of the pathogenesis and optimal treatment of kidney disease and hypertension. The Training Program proposes to train clinicians and scientists to better understand kidney physiology and disease and the pathophysiology of hypertension disorders. A better understanding of kidney disease and hypertension will lead to better prevention and treatments of the disorders.